Shared Resource Management

PROJECT SUMMARY – SHARED RESOURCES MANAGEMENT
The Ohio State University Comprehensive Cancer Center (OSUCCC) manages and supports 16 CCSG-funded
Shared Resources (SRs) and is proposing two developing shared resources in this application. The goals of the
OSUCCC SRs are to support OSUCCC members by providing specialized technologies, services, and expertise
that maximize quality and speed of service, while maintaining cost-effectiveness and quality control. The SRs
support all five Research Programs and are managed by faculty from seven different colleges and Nationwide
Children’s Hospital. Most of the SRs are centrally located and in close proximity to OSUCCC members. The
Specific Aims for Shared Resource Management are to: 1) evaluate for need, and establish new specialized
technologies, services and expertise that enhance scientific interaction and productivity; 2) ensure that the SRs
provide cost-effective, reliable, and quality-controlled technologies, services and expertise; 3) support SRs
through budget planning, laboratory management systems, and sustainability; and 4) establish policies for SR
access and use. The OSUCCC directly manages 13 of the 16 SRs, and the others are jointly managed as
institutional SRs that follow NCI policies. Reporting to the OSUCCC Director, the SRs are led by Sharyn Baker,
PharmD, PhD, Associate Director for Shared Resources. Dr. Baker works with Heather Hampel MS, LGC,
Associate Director for Biospecimen Research for integration of biospecimen services with the SRs. Dr. Baker
leads the Shared Resource Team Leader (SRTL) committee that oversees SR management and implementation
of the scientific vision. The SRTL monitors quality and user satisfaction through user surveys and user
committees. SR development and evaluation is provided to Dr. Baker from the Associate Directors Committee,
Program Leaders, and the External Scientific Advisory Board. Shared Resource Management operations include
ensuring compliance with OSUCCC policies (prioritization of use and access, budgets, billing, and quality control)
and compliance with OSU Office of Research policies and the federal Uniform Guidance. For the evaluation of
new instrumentation and services, Dr. Baker manages the Intramural Research Program (IRP) that provides
external peer review of SR applications, evaluating scientific merit and planned usage ($3.4M awarded this grant
cycle. Overall support to the SRs over the last grant cycle has been $18M, allowing for all of the SRs to have
been enhanced and offer new services. Future plans for each SR are accounting for planned increased usage
due to the OSUCCC strategic research priorities and planned recruitment. The OSUCCC provides over $9M in
overall support of the SRs annually, The OSUCCC is requesting a total of $1,971,340 in CCSG funding, 8.9%
of the total support.